New Approaches to the Evaluation and Treatment of Acromegaly

DESCRIPTION (provided by applicant): The overall goal of this project is to support my continued professional development as an independent patient-oriented investigator and successful mentor. A focus of my research has been to establish and validate optimal biochemical endpoints for acromegaly therapy based on highly sensitive GH and IGF-I measurements utilizing a uniquely large cohort of patients that I have established. We are now also assessing clinical endpoints of acromegaly therapy. This recent work has identified novel changes in body composition in patients with acromegaly. These findings have led us to hypothesize that a GH-IGF-I excess specific dysregulation of adipose tissue (AT) and lipodystrophy occur which is characterized by reduced central AT depots yet increased AT in muscle and may contribute to insulin resistance and increased cardiovascular risk. Acromegaly therapy may reverse this lipodystrophy, but in some patients this may increase central AT stores and thereby increase inflammation in AT as well as in circulation. This application's first 4 scientific aims, funded by my R01 DK064720, test how the lipodystrophy and its recovery affect AT inflammation, adipokines, appetite hormones, endothelial function, cv risk markers and long-term outcome in acromegaly. We will utilize techniques novel to acromegaly studies including examinations of muscle lipid by MR spectroscopy, adipose tissue for macrophage infiltration and inflammation and endothelial cells for markers of endothelial dysfunction. Understanding the consequences of this lipodystrophy and its reversal are crucial because they may be of long-term clinical significance. This study, the only one on acromegaly funded by the NIH, will provide novel important data which is also applicable to our understanding of the effects of GH use and over-use in other clinical settings. This application includes a new investigation (Aim 5) into the affect of GH/IGF-I excess and its treatment on the skeleton. Fractures are increased in acromegaly, but bone mineral density (BMD) is not reduced. Utilizing the novel assessment of bone architecture by HRpQCT along will BMD, fracture prevalence and bone metabolism marker measurements we will determine, among other endpoints, if bone architecture (by HRpQCT) is impaired in patients with a seemingly normal BMD due to an artifact of increased bone size. My productive, ongoing, NIH funded clinical research program, my successful mentoring track record and my 16 years of experience in patient-oriented research make me well suited for renewal of the K24 award. The additional funds provided by the K24 will allow me to maintain my high level of effort on NIH funded patient-oriented research and mentoring. Without it my clinical and administrative duties would be greatly increased with detrimental impact on current and future mentees' training. The institutional environment at Columbia, with a strong and diverse Endocrine Division, CTSA, CRC, Diabetes and Obesity Research Centers, is ideal for attracting fellows and conducting our research. Renewal of this award is an ideal mechanism to ensure the continued support I need to maintain my success as a mentor and clinical researcher.

Public health relevance
PUBLIC HEALTH RELEVANCE: Acromegaly, a rare disease due to a growth hormone producing pituitary tumor, is associated with increased morbidity and mortality. In this project we will utilize modern biochemical methods, novel techniques and a uniquely large, ongoing prospective acromegaly cohort study to characterize novel features of acromegaly including an abnormal fat distribution that may contribute significantly to its increased morbidity and mortality. Our study will lead to important knowledge about the effects GH and IGF-I on body composition, adipose tissue inflammation, endothelial dysfunction, bone density and cardiovascular risk, which is also applicable to our understanding of the effects of GH use and over-use in other clinical settings. PROJECT NARRATIVE Acromegaly, a rare disease due to a growth hormone producing pituitary tumor, is associated with increased morbidity and mortality. In this project we will utilize modern biochemical methods, novel techniques and a uniquely large, ongoing prospective acromegaly cohort study to characterize novel features of acromegaly including an abnormal fat distribution that may contribute significantly to its increased morbidity and mortality. Our study will lead to important knowledge about the effects GH and IGF-I on body composition, adipose tissue inflammation, endothelial dysfunction, bone density and cardiovascular risk, which is also applicable to our understanding of the effects of GH use and over-use in other clinical settings. __SpecificAimsTextDelimiter__ RESEARCH PLAN AIMS 1-4 are abbreviated from my funded R01 (DK064720-06) and AIM 5 is an additional new study. SPECIFIC AIMS Our ongoing unique prospective study of over 200 acromegaly patients has redefined biochemical goals for treatment based on modern GH and IGF-I assays. With new potent medical therapies these goals can be met and therapy finely tuned, but whether this effectively corrects important newly identified and classic acromegaly morbidities needs to be established. Although acromegaly patients are predisposed to cardiovascular (cv) disease because of metabolic abnormalities their etiology and link to it may not be analogous to that of the metabolic syndrome in others. Rather, we hypothesize that a distinct GH/IGF-I excess-induced adipose tissue (AT) dysregulation driven by accelerated lipolysis and a resultant lipodystrophy exists. This lipodystrophy, characterized as our novel data show, by reduced visceral (V) and subcutaneous (S) AT mass yet increased inter-muscular adipose tissue (IMAT), may be central to metabolic abnormalities and adipokine dysregulation in acromegaly. Optimal treatment should reverse this lipodystrophy, but in some patients this also results in weight gain and a rise in a serum inflammatory marker, crp. These may be linked and we hypothesize that recovery of the lipodystrophy increases AT mass and its inflammation, which may predispose patients who may be inadvertently over-treated, in particular, to an increased cv risk in the long term. Postoperative increases in the appetite-stimulating hormone, ghrelin, may also play a role in weight gain. We will employ novel examinations of muscle and hepatic lipid by proton MR spectroscopy and AT and endothelial cells by biopsy to characterize how the lipodystrophy and its recovery affect AT inflammation, adipokines, appetite hormones, endothelial function, cv risk markers and long term outcome in acromegaly. This application includes a new investigation (Aim 5) into the affect of GH/IGF-I excess and its treatment on the skeleton. Fractures are increased in acromegaly, but bone mineral density (BMD) is generally not reduced. Utilizing the novel assessment of bone architecture by high-resolution peripheral quantitative computed tomography (HRpQCT) along will BMD, fracture prevalence and markers of bone metabolism measurements to determine, along with other endpoints, if bone architecture is impaired in patients with a seemingly normal BMD due to an artifact of increased bone size. This study will provide important novel data about GH, IGF-I and the skeleton. AIM 1: To characterize the lipodystrophy and pattern of adipose tissue deposition in active acromegaly and its change with therapy of acromegaly. 1a) To determine if adipose tissue is decreased in VAT and SAT depots, but increased in muscle by increases in IMAT (by MRI) and intra-myocellular lipid (IMCL)(by 1H MRS) as well as in liver (by 1H MRS). 1b) To determine if increased muscle lipid is associated with insulin resistance and how acromegaly therapies and the resultant changes in insulin resistance impact on the change in the lipodystrophy of GH/IGF-I excess. 1c) To determine how acromegaly treatment to different IGF-I level targets across the normal spectrum affects the pattern of change in its lipodystrophy and metabolic abnormalities. 1d) To determine which body composition changes account for weight gain after therapy. AIM 2: To examine adipose tissue inflammation and adipokine expression and serum markers of inflammation and adipokine levels in the lipodystrophy of acromegaly and its recovery. 2a) To determine if AT inflammation and adipokine expression are reduced in active acromegaly and increase with GH/IGF-I normalization. 2b) To determine if circulating inflammatory marker and adipokine levels are reduced in active acromegaly and increase in parallel with adipose tissue inflammation and VAT & SAT. AIM 3: To examine changes in the appetite hormone, ghrelin, in acromegaly and its recovery. To determine if recovery of the disordered ghrelin secretion of active acromegaly and increases in circulating ghrelin levels parallel weight gain and increased appetite, improved insulin sensitivity and decreased energy expenditure with therapy that reverses the lipodystrophy of acromegaly. AIM 4: To determine the consequences of the GH/IGF-I excess and its recovery on endothelial cell function, cardiovascular risk profile, body composition and long-term outcome in our ongoing prospective cohort study in acromegaly. 4a) To determine if endothelial cell dysfunction assessed by biopsy is present in active acromegaly and if it improves with GH/IGF-I or insulin resistance lowering. 4b) To determine how GH/IGF-I levels within and across our new normal spectrum relate to insulin resistance, body composition, serum markers of cv risk and long term morbidity and mortality outcomes in acromegaly. AIM 5: To assess bone micro-architecture by HR-pQCT, BMD by DXA, vertebral fractures and indices of bone turnover and mineral metabolism in patients with acromegaly before and after treatment.